Small Things First: Leveraging Implementation Science to Increase Access to Infant Directed Speech for ALL Infants in Neonatal Intensive Care Units

Project Summary/Abstract
Adequate language input is required for typical language development. However, NICU infants are at particularly
high risk for experiencing a language deprived environment and may spend weeks-to-many-months of a critical
developmental period in this setting. Importantly, we know that the language environment of the NICU matters:
the quantity and quality of language input an infant receives in the NICU has been associated with positive
short-and-long-term outcomes (e.g., attentiveness, alertness, vocalizations, conversational turns, language,
development). Infant directed speech (IDS), is a highly promising language construct, that is defined as a pattern
of speaking adults use with infants and young children that has a simpler phonology, grammatical structure, and
fewer lexical items as well as a higher pitch and unusual intonation pattern. Increased use of IDS has been found
to be predictive of better language outcomes in typically developing infants. Increasing the quantity of IDS in the
NICU may be a simple, low-training, high-impact intervention that could bolster early language outcomes for
NICU infants (e.g., verbalizations, conversational turns). For NICU infants, it is imperative that we task both
parents and clinicians as co-primary providers of routine IDS due to significant existing barriers to parent
visitation. However, tasking clinicians to use IDS during routine care will likely face organizational, innovation,
and clinician-level barriers that may impact clinician intentions. To successfully increase all infants’ access to
IDS, it is necessary to conduct preliminary implementation research prior to a Hybrid Type 1 (effectiveness-
implementation) study to identify and understand: 1) barriers to parent visitation and intentions to use IDS with
their hospitalized infant (with semi-structured interviews, surveys); and 2) identify and understand barriers and
facilitators to NICU clinician use of IDS (with surveys, video-elicitation interviews; video simulation surveys). To
conceptualize this work, we are modifying the Explore Plan Implement Sustain implementation framework to
incorporate health equity factors as part of the outer context and use organizational and psychological theories
of behavior to explore and refine a possible causal model of contributors to parent and clinician intentions to use
IDS with NICU infants. Completing the proposed research will allow us to refine our causal model by identifying
an exhaustive list of societal, organizational, innovation, and individual factors (i.e., barriers, facilitators) that may
impact or moderate parent intentions to visit and parent and clinician intentions to use IDS in the NICU. Finally,
the training and research activities proposed in the K23 application will support the PI in having the data, skills,
and experiences necessary to submit a strong application for a multi-site Hybrid Type I (effectiveness-
implementation) trial that examines 1) whether we can significantly increase adult use of IDS in the NICU (i.e.,
parent/visits, clinician/routine care); and 2) whether infants who received higher levels of IDS demonstrated more
verbalizations, vocalizations, and conversational turns at discharge (adjusting for gestational age).

Public health relevance
Project Narrative Adequate language input is required for typical language development, however, NICU infants are at particularly high risk for experiencing a language deprived environment early in development and may spend weeks-to- many-months of a critical developmental period in this setting. Importantly, we know that the language environment in the NICU matters: the quantity and quality of language input NICU infants receive has been associated with positive short-and-long-term outcomes (e.g., alertness, attentiveness, verbalizations, vocalizations, language). In this proposal, the applicant will engage in mentoring, training, and research activities to leverage implementation science frameworks, health equity constructs, and psychological and organizational theories to refine a proposed causal model of parent and clinician intentions to use IDS with NICU infants in preparation for a Hybrid Type 1 (effectiveness-implementation) trial that emphasizes intervention accessibility.